Characterizing the Sexually Dimorphic Role of Topoisomerase II During the Sister Chromatid Cohesion Release Pathway.

PROJECT SUMMARY
People in every socioeconomic class, both males and females, and every nationality and ethnicity are affected
by infertility. Aneuploidy is the leading cause of infertility, as well as birth defects, and miscarriages. Aneuploidy
occurs when there are errors in the specialized cell division of meiosis. Meiotic success is dependent on proper
segregation of homologous chromosomes at meiosis I, and then subsequent sister chromatid segregation at
meiosis II. There is still much that is unknown about the molecular mechanisms that contribute to infertility, and
even less is known about the sexually dimorphic mechanisms during gametogenesis that can be contributing
factors. The overall goal of the lab is to determine how these sexually dimorphic molecular mechanisms
contribute to infertility. The goal of this proposal is to characterize the sex-specific roles of an enzyme crucial
for relieving topological abnormalities in DNA during male and female meiosis. This enzyme, Topoisomerase II
(Topo II), has been shown to have sex-specific phenotypes in both spermatogenesis and oogenesis in a
variety of model organisms. Topo II also has roles in chromosome structure, condensation, and is a
chromosome axis component in both mitosis and meiosis. Preliminary data indicates that Topo II also plays a
role in the release of sister chromatid cohesion, an important step in ensuring the success of meiosis. The
goals of this proposal will take a combined genetic, molecular biology, and biochemical approach to determine
the sex-specific role of Topo II in meiosis. To achieve this, the applicant will be advised by a mentoring team
that includes a sponsor with expertise in the fields of Meiosis and Genetics, as well as a co-sponsor who is an
expert in Biochemistry, including protein expression, purification, and function. The collaboration between the
candidate and her sponsors provides her with mentorship that is unique, interdisciplinary, and allows for the
opportunity to develop a skillset that will be utilized throughout the entirety of her academic career, from post-
doc to independent researcher. The resources, facilities, equipment, and faculty, available at the University of
Delaware far exceed the needs of the proposal, ensuring a successful training environment to complete the
aims proposed. Aim 1 uses single chromosome fluorescence labeling and nano-resolution microscopy to
characterize the sexually dimorphic role of TOP-2 on sperm chromosome structure in late meiotic prophase l. I
will also use a combination of genetic and confocal microscopy to determine the role of TOP-2 on oocyte
chromosomes. Aim 2 will determine the differential protein interactions of TOP-2 in spermatogenesis and
oogenesis using a biochemical approach in vivo and in vitro. These aims are innovative in the field of meiosis
because the mechanisms known to govern the sex-specific differences in spermatogenesis and oogenesis are
still largely unknown, exploring the role of Topo II will give us insight into one of the many functional and
regulatory differences between male and female gametogenesis.

Public health relevance
PROJECT NARRATIVE The tight regulation of meiosis, the specialized cell division that results in haploid gametes (sperm and eggs) is crucial for proper ploidy (correct number of chromosomes). Perturbations in meiosis can lead to gametes with the wrong number of chromosomes, which is the leading cause of infertility, miscarriages, and birth defects. The results from this proposal will begin to determine the sex-specific mechanisms that contribute to gametes with the correct ploidy providing a further understanding for the differences in male vs. female infertility.